The Impact of Tobacco Control Policies on Health Equity in the United States - MERIT Extension

Abstract
This MERIT extension to The Impact of Tobacco Control Policies on Health Equity in the United
States study (R37CA214787) will provide funding to build upon the research under the parent
grant to examine how tobacco policies interact to affect youth smoking disparities, and how
tobacco control policies affect youth e-cigarette use and related disparities. The parent grant
investigates how tobacco control policies affect smoking initiation and cessation differentially by
sex, race/ethnicity, and socioeconomic. The MERIT extension would expand upon the work of
the original award by (1) analyzing the potential for different tobacco control policies to interact
to affect youth smoking initiation and disparities in initiation, and (2) examining how the
implementation of tobacco control policies impact the use of e-cigarettes among youth, and
disparities in use by sex, race/ethnicity, and SES. The proposed extension will leverage
knowledge and policy databases built during the original grant to carry out the new aims.
Knowledge learned from this supplement will help us better understand how policies work
together to affect youth smoking disparities, and how policies affect youth e-cigarette use.

Public health relevance
Project Narrative The proposed research study will investigate the interaction of tobacco control policies on youth smoking disparities, and the influence of tobacco control policies on youth e-cigarette use and related disparities. The proposed research project compliments and expands on the aims of the parent R37, The Impact of Tobacco Control Policies on Health Equity in the United States (R37CA214787), and will contribute to the parent grant’s goal for understanding the health equity impact of tobacco control policies in the United States.